Neutral sphingomyelinase-2 as a mediator of Doxorubicin-induced cardiotoxicity

ABSTRACT
Doxorubicin (Dox) is a mainstay in the treatment of many cancers yet its utility is limited by cardiovascular toxicity.
While multiple mechanisms underlying this cardiotoxicity have been proposed, strategies targeting these
pathways have had marginal effects or interfere with anti-cancer effects of the drug. Such concerns have
restricted the clinical use of dexrazoxane which is currently the only FDA-approved cardio-protective agent. As
cancer survival rates improve and more patients are exposed to Dox, there is a critical need for new strategies
to mitigate the cardiotoxicity without comprising its therapeutic efficacy. Bioactive sphingolipids (SLs), especially
ceramide (Cer), are well-established mediators of the chemotherapy stress response across diverse cancers.
While this increased interest in targeting SL metabolism to enhance chemotherapy responses, targeting SL
metabolism to reduce chemotoxicities is largely unexplored. We recently identified the Cer-generating enzyme
neutral sphingomyelinase-2 (nSMase2) as a primary Dox-regulated SL enzyme in breast cancer. Here, our
preliminary studies begin to implicate nSMase2-derived Cer in the Dox-induced DNA damage response of
cardiomyocytes (CMs) and show that in vivo loss of nSMase2 activity protects from the onset of Dox-induced
cardiac dysfunction and damage. Crucially, nSMase2 appears to be dispensable for the in vitro and in vivo anti-
cancer effects of Dox on breast cancer. Based on these data, the central hypothesis is that the nSMase2-
ceramide pathway is essential for Dox-induced cardiotoxicity but dispensable for Dox-induced anti-cancer
activity. We propose three specific aims: The first aim will establish Dox-induced activation of the nSMase2-
Cer pathway in cardiac cells and tissues combining in vitro and in vivo approaches to establish nSMase2
induction in CMs as a major pathway of Dox-induced Cer generation in the heart. The second aim will define
the role of the nSMase2-Cer pathway in mediating Dox-induced cardiotoxicity using in vitro and in vivo loss
of function approaches to establish nSMase2 in CMs as a mediator of Dox-induced CM cell death and cardiac
fibrosis. The third aim will establish the therapeutic potential of nSMase2 inhibitors as cardioprotective
agents that do not interfere with the anti-cancer activity of Dox using syngeneic xenograft models of breast
cancer to demonstrate the efficacy of nSMase2 inhibitors as cardioprotective agents that do not interfere with
Dox reduction of tumor growth and metastasis. Overall, these studies will provide novel insight into the
pathogenesis of Dox-induced cardiotoxicity and establish nSMase2 as a novel druggable target for
cardioprotection. This will provide a rational basis for the development of nSMase2 inhibitors as novel
cardioprotective agents.

Public health relevance
Although a mainstay for treatment of many cancers, the clinical utility of Doxorubicin (Dox) is severely limited by cardiotoxicity and there is a critical need for new therapies to mitigate these adverse effects but without interfering its efficacy against cancer. The proposed research will establish the sphingolipid enzyme nSMase2 as a mediator of Dox-induced cardiotoxicity through effects on cardiomyocyte cell death and cardiac fibrosis, and in proof-of- principle studies will demonstrate that nSMase2 inhibitors reduce cardiotoxic effects of Dox but without impacting its anti-cancer activity. Collectively, these studies will advance our basic understanding of the pathogenesis of Dox-induced cardiotoxicity and will establish nSMase2 as a novel and viable druggable target for cardioprotection.